Cryogenic nanoimaging of AAV infection and packaging.

Project Summary/Abstract
Gene therapies based on adeno-associated virus have garnered significant clinical
success, but they are limited by factors including: unidentified blocks to genome
delivery from the perinuclear region to the nucleus, lack of targeting control, and limits
on maximum transgene length. This first factor is the foremost bottleneck affecting
particle:infectious dose ratio. Due to this ratio, large doses are required in clinical
practice, which drives side effects and limits which indications AAV gene therapy can be
used for.
The molecular basis of each of these impediments has been unclear, but recently-
developed methods of cryo-electron-microscopy-based nanoimaging finally offers our
field the tools it needs to directly observe key infection/transduction steps in situ. In this
project, we will directly observe perinuclear and intranuclear virions by cryo-focused ion
beam micromachining and electron tomography (as well as by an orthogonal optical
method). This will enable us to finally determine where and how the viral genome leaves
the capsid and how the “stuck” virions differ from those that delivered genomes.
Similarly, using ultrathin cells to facilitate direct cryo-electron tomography, we will
determine the subnanometer-resolution structures of cell-attached virions to clarify
questions surrounding receptor binding. Finally, we will chemically and genetically
perturb genome packaging to elucidate determinants of packaging and, in the case of
one intervention, perhaps even increase the maximum possible insert length. We expect
that the expanded understanding of the structural basis for blocks to infection plus
biochemical details of virion state along the infection pathway will provide a basis for
AAV rational design efforts by both basic and applied/translational researchers.

Public health relevance
Project Narrative Despite clinical success for some diseases, AAV gene therapy is severely limited by its inefficiency and the concomitant need for high doses. Using cryo-electron microscopy nanoimaging methods including subdiffraction optically-targeted ion beam micromachining of infected cells, we will observe viral particles at various stages during the infection process to understand the series of events that are required for successful delivery of genes to the nucleus, with a focus on those events that limit the efficiency of delivery.